Understanding OPA1 mutation-driven dominant optic atrophy using human PSC-derived retinal ganglion cells

PROJECT SUMMARY/ABSTRACT
Dominant optic atrophy (DOA) is the most prevalent genetic optic neuropathy, affecting roughly 1:12,000 to
1:50,000 individuals worldwide. DOA patients exhibit retinal ganglion cell (RGC) degeneration, which leads to
progressive bilateral vision loss. The majority of DOA cases are caused by mutations in the gene optic atrophy
1 (OPA1), a nuclear gene that encodes a protein targeted to the inner mitochondrial membrane. Interestingly,
although OPA1 is ubiquitously expressed in all human tissues, RGCs appear to be the only cell type affected by
OPA1 mutations. It is therefore essential to study DOA in human RGCs in order to understand the pathological
mechanisms present in these cells that render them particularly prone to degeneration. However, studies of
human RGCs have been historically difficult due to the rarity of primary retinal tissues and scarcity of RGCs,
which only comprise ~2% of the total retinal cells. This proposal seeks to address the significant unmet need for
developing human RGC models of DOA. Advances in stem cell technology have enabled our laboratory to
routinely produce human RGCs from human pluripotent stem cell (hPSC)-derived 3D retinal organoid cultures.
In addition, I have established OPA1 mutant hPSC lines by using gene editing technology and by reprogramming
DOA patients’ peripheral blood cells. Differentiating these OPA1 mutant hPSC lines into retinal organoids will
provide the first opportunity to establish DOA disease models in authentic, human RGCs. In the proposed study,
I will use OPA1 mutant hPSC-derived human RGC populations to investigate pathological mechanisms of OPA1
mutation-mediated RGC degeneration. As OPA1 plays significant roles in promoting mitochondrial fusion,
maintaining the integrity of the cristae, and stabilizing super complexes of the respiratory chain, RGC death
observed in DOA patients is likely a result of mitochondrial defects that can lead to an insufficient energy supply,
increased oxidative stress, and/or leakage of cytochrome c into the cytoplasm. I will investigate the mitochondrial
dynamics, cristae structure, and metabolic state of OPA1-mutant RGCs to delineate whether changes in these
fundamental processes underly the RGC degeneration observed in DOA patients. Findings from this study will
advance our understanding of the pathological mechanisms affecting DOA patients’ RGCs and facilitate the
development of therapies that can preserve or rescue vision in DOA patients. Additionally, our findings could
provide important insights into other neurodegenerative diseases that share common metabolic deficiencies with
DOA.

Public health relevance
PROJECT NARRATIVE Dominant optic atrophy (DOA) is the most prevalent optic neuropathy, leading to progressive bilateral vision loss as a result of retinal ganglion cell (RGC) degeneration. This proposal aims to use human pluripotent stem cell derived-RGC models of DOA generated by our lab to investigate mitochondrial and metabolic mechanisms underlying RGC degeneration observed in DOA patients. Findings from this research will provide important insights into DOA’s pathological mechanisms, as well as insights into other neurodegenerative diseases that share common metabolic deficiencies with DOA.